Core B: Protein Expression Core

Biochemical, structural, and immunization experiments to evaluate new immunogens designed
and selected to induce broadly neutralizing antibodies will require expression and purification of
large numbers of proteins, including HIV envelope proteins and antibodies. The Protein
Expression Core will provide purified proteins for this program project, which will facilitate the
goals of identifying immunogens and defining immunization strategies that elicit a strong and
targeted immune response. Antibodies isolated from immunized mice (Project 1) will be
expressed and purified for binding and biochemical characterization as well as for structural
studies (Project 2). Env proteins, both monomeric gp120s and native-like Env gp140 trimers
(SOSIP.664 constructs), will be expressed for immunizations in Project 1, binding studies in
Projects 1 and 2, and structural/biochemical analyses in Project 2. Core B will use various
expression systems to produce Env proteins with different glycosylation to determine the effects
of glycosylation form on the generated immune response. The large number of different
antibodies and HIV proteins to be expressed and purified for this program requires a dedicated
protein expression core.